A novel monobody-drug conjugate to treat mutant Ras multiple myeloma

Project Summary: Tezcat is an early-stage biopharmaceutical company developing novel
biologics with a unique mechanism of action to treat the most recalcitrant cancers, such as mutant
RAS multiple myeloma. Multiple myeloma is an incurable hematologic malignancy with an
expected median survival of 7-8 years. Despite an initial response rate approaching 90% to
proteasome inhibitor-containing combinations, all patients relapse and eventually become
resistant to any treatments. Approximately 70% of these relapse/refractory patients harbor a
mutation in RAS. We have observed that mutant RAS multiple myeloma cells display high levels
of macropinocytosis, a nutrient scavenging process that facilitates the bulk engulfment of
extracellular fluid and its solutes. Our drug candidate, TZT-102, utilizes our proprietary
macropinocytosis-selective monobody that carries an FDA-approved cytotoxic payload. Results
from our Phase I STTR project demonstrate that TZT-102 has robust anti-tumor activity in mutant
RAS MM xenograft models without showing toxicity issues. Based on the success of our Phase I
aims, we have proposed a Phase II SBIR program for investigators at Tezcat to advance TZT-
102 through Specific Aims that will pursue bioanalytical assay development (Aim 1) and non-GLP
toxicology studies in rats (Aim 2) to prepare for a pre-IND meeting with the FDA (Aim 3). We
further propose to use an Administrative Supplement to initiate bioanalytical assay validation
efforts for the detection of the full TZT-102 conjugate and the free drug payload in rat plasma, that
will subsequently be used for IND-enabling toxicology studies. Tezcat has entered into a license
agreement with NYU Langone Health for exclusive, worldwide rights to the technology being
developed. The commercialization strategy will be based on further development through the ong-
going Phase II SBIR studies and towards IND status and first-in-human clinical trials via a strategic
partnership. Thus, we expect this Phase II SBIR and the Administrative Supplement to provide
additional support for pursuit of GMP protocols and GLP safety and toxicity studies to support
IND submission with the FDA.

Public health relevance
Project Narrative: Tezcat Biosciences is an early-stage biotechnology company focused on developing innovative therapeutics to treat mutant RAS cancers. In this Phase II SBIR, Tezcat is further developing a proprietary monobody-MMAE conjugate for treatment of multiple myeloma.